Regulation of a chromatin modifier (Polycomb Repressive Complex 2) by nucleic acids interactions

Summary/abstract
Polycomb repressive complex 2 (PRC2) is an essential histone methyltransferase required for epigenetic
silencing in development. Upregulation of PRC2 or its methyltransferase activity is frequently observed in
cancer and can be critical for cancer cell proliferation and progression. Despite many efforts in reducing the
expression level of PRC2 and inhibiting its catalytic active site in treatment of diseases, PRC2-nucleic acid
interactions have been underestimated as important processes to regulate recruitment and catalytic activities
of PRC2. It has been recently demonstrated by our group and others that RNA binding inhibits catalytic
activities of PRC2, indicating that mutations of RNA binding residues of PRC2 subunits could be an alternative
way to upregulate PRC2 activity and indeed such mutations have been observed in cancer (R34L, K39E,
K491R and R494S in EZH2, the catalytic subunit of PRC2). Moreover, a few long noncoding (lnc)RNAs have
emerged as key playmakers to recruit or evict PRC2 from chromatin loci to regulate specific gene expression
in development and diseases, but understanding the physiological functions of RNA binding of PRC2 has been
hampered previously by the lack of separation-of-function mutant, which has been finally identified in my recent
publication (Long et al. eLife 2017). More recently, PRC2-DNA interaction has been shown to drive the
interaction of PRC2 with nucleosome, and DNA-binding domains reside on multiple accessory subunits of
PRC2 complex including AEBP2, JARID2, PHF1, MTF2 and PHF19. However, the genome-wide function of
these DNA interactions has not been comprehensively investigated. To answer all these critical questions on
PRC2 regulation, I propose a comprehensive in vitro and in vivo investigation of the molecular mechanisms
and cellular functions of PRC2-nucleic acid interactions. Specifically, this proposal aims to: (1) understand how
RNA interactions regulate cellular activities of PRC2; (2) understand how DNA regulates PRC2 through
interaction with PRC2’s accessory proteins. During the K99 phase, under the mentorship of Dr. Tom Cech and
Dr. John Rinn, comprehensive approaches using in vitro biochemical analysis and in vivo genome-wide
characterization will be used to determine molecular mechanism and function of PRC2-nucleic acid
interactions. With support from Dr. Leslie Leinwand, expertise in analyzing cardiomyocyte physiology and
behavior will be acquired in order to identify important biological consequences of loss of nucleic acid
interaction of PRC2 in cardiomyocytes, in which PRC2 activities have been shown to be critical. Additional K99
training in genomics and computational biology will be essential for the proposed research. All training above
will facilitate continued investigations of functions of PRC2-nucleic acid interactions during the independent
R00 phase. The results of this proposal will not only lead to identification of important PRC2-nucleic acid
interactions and their molecular mechanisms, but also provide a paradigm for characterizing other epigenetic
modifiers that bind nucleic acids especially noncoding RNAs.

Public health relevance
Narrative Polycomb repressive complex 2 (PRC2) is responsible for healthy embryonic development through the epigenetic repression of genes during differentiation, and mutation or overexpression of PRC2 subunits has been linked to many forms of cancer and nervous system disorders. Interactions with RNA and DNA are critical cellular events that regulate the epigenetic activities of PRC2, and mutations among the residues that bind nucleic acids have been observed in cancer. Understanding the molecular mechanism and functions of PRC2- nucleic acid interactions could help in treatment of diseases related to PRC2, including genetic therapy using RNA to inhibit hyperactive PRC2 in a locus-specific manner and drug design to specifically disrupt PRC2- nucleic acid interactions to prevent abnormal PRC2 recruitment in diseases.